2-Generation Interventions to Improve Cardiovascular Health in Indiana and Illinois Through Home Visiting (2-NOURISH)

PROJECT SUMMARY
This application proposing the 2-GeneratioN Interventions to ImprOve CardiovascUlaR Health in Indiana and
IllinoiS Through Home Visiting (2-NOURISH) is in response to the RFA “Early Intervention to Promote
Cardiovascular Health of Mothers and Children (ENRICH) Multisite Clinical Center (RFA-HL-22-007)”. Given
growing rates of maternal morbidity and mortality, interventions to optimize maternal cardiovascular health
(CVH) are urgently needed. Poor maternal CVH is also associated with poor offspring CVH. As a result, the
perinatal period is an opportune time to intervene, but evidence-based interventions are limited. Home visiting
(HV) programs serve as an ideal setting to conduct intervention research aimed at improving maternal and
child CVH as they already serve an at-risk population across the United States with a high prevalence of poor
CVH. The proposed Clinical Center, 2-NOURISH, led by Northwestern, in partnership with two evidence-based
HV models (Healthy Families America [HFA] and Parents as Teachers [PAT]), and an evidence-based virtual
platform for lifestyle intervention, Weight Watchers International (WW), is uniquely qualified to participate in all
aspects of the ENRICH Network and to substantially enhance the Network’s goals. In our application, we
demonstrate key prior experiences, which include: (1) long-standing collaborations with HV models, including
MPI Tandon’s evidence-based perinatal depression and stress management intervention (Mothers and
Babies); (2) significant expertise in the development and assessment of maternal and child CVH, particularly
during the perinatal period; and (3) extensive experience with recruitment and retention of diverse populations
for behavior interventions. During the UG3 phase (Years 1-2), we will work collaboratively within the ENRICH
Network to develop a common study protocol, adapt the intervention content, and conduct pilot tests. During
the UH3 phase (Years 3-7), we will recruit 600 mother-child dyads in partnership with 40 HV programs in
Illinois and Indiana within the proposed study timeline to achieve the ENRICH Network Goal of 3000 total
dyads to examine the effectiveness of an implementation-ready, CVH-focused, evidence-based intervention.
We carefully considered potential study designs and propose a Hybrid Effectiveness-Implementation Type 1
trial with a cluster randomized design that would randomize at the home visitor-level. Additionally, given the
potential maternal and offspring benefits of intervention during pregnancy, we propose prenatal recruitment.
Our proposed intervention also includes innovative prenatal (promotion of stress management techniques,
home visitor patient navigation) and postpartum (intensive lifestyle intervention with a virtual delivery platform,
peer support) components. Our Clinical Center is additionally committed to developing the skills of Early Stage
Investigators related to clinical trial design and the skills of home visitors related to the construct of CVH, its
components, and the common study protocol. 2-NOURISH is ideally suited to serve as a Clinical Center and
contribute to the Network’s long-term mission to equitably improve maternal and early childhood CVH.

Public health relevance
PROJECT NARRATIVE Pregnancy is a key period to optimize maternal and offspring cardiovascular health. In this project, we will collaborate with the NHLBI and the ENRICH Network to test whether a multi-component intervention delivered in the context of home visiting will improve maternal and child cardiovascular health. This project may have great benefit to society, as interventions delivered in the perinatal period have the potential to influence lifelong cardiovascular health across generations.